Effect of Hypercapnia Treatment on Respiratory Recovery after Spinal Cord Injury

Project Summary Abstract
Title: Effect of Hypercapnia Treatment on Respiratory Recovery after Spinal Cord
Injury.
Respiratory and cardiovascular complications are the most common causes of death in
the first year post-injury. Nearly 80% of patients with SCI, including Veterans, suffer from
breathing and sleep disorders after six months of injury. However, most patients with
SCI do not tolerate standard mechanical treatment leading to a lack of adherence.
Therefore, identifying other therapies is important for this common condition linked to
poor outcomes in the general population (heart disease, stroke, hypertension, and poor
cognition). In individuals with SCI, it has been reported that chemical stimulation using
acute intermittent hypoxia techniques improves ventilatory and motor recovery. The
effect of intermittent hypoxia is dependent on the level of alveolar Carbon Dioxide (CO2)
and may pose undesirable cardiovascular effects. However, the effect of hypercapnia
alone on respiratory recovery during wakefulness and sleep in patients with SCI is
unknown.
The purpose of this application is to identify new therapeutic interventions for respiratory
and sleep disorders in Veterans with SCI. This application proposes a pilot study to
enroll 30 Veterans with SCI to receive two weeks of daily acute intermittent hypercapnia
(dAIHc) treatment. There will be three specific aims to address the following hypotheses:
Specific Aim (1): Measure the recruitment rate and feasibility of a pilot intervention
using dAIHc in individuals with SCI.
Specific Aim (2): Test the hypothesis that dAIHc will increase minute ventilation and
respiratory muscle forces in individuals with SCI.
Specific Aim (3): Test the hypothesis that dAIHc will improve sleep parameters in
individuals with SCI.

Public health relevance
It is estimated that spinal cord injury (SCI) affects approximately 12,000 new individuals every year in the United States, with the majority are cervical and/or upper thoracic injuries. Despite this high prevalence of respiratory and sleep disorders in the chronic SCI population minority of patients are treated and are adherent to standard mechanical therapies. This proposal addresses a new therapeutic intervention in SCI. We hypothesized that daily acute intermittent hypercapnia (dAIHc) is feasible, improves respiratory symptoms, and alleviates sleep apnea in patients with chronic SCI. We will perform a pilot feasibility study to examine the impact of dAIHC for two weeks durations among Veterans with SCI. We believe that this novel approach to treating OSA will yield significant new knowledge that improves the health and quality of life of these patients.